Molecular Mechanisms Associated with Insomnia and Response to Cognitive Behavioral Therapy for Insomnia

Sleep disturbances highly prevalent conditions, especially following traumatic brain injury (TBI); ~60% of patients
with TBI have insomnia. Chronic sleep disturbances impair daily functioning, negatively impact quality of life, are
linked to impaired cognition and alertness, and contribute to depression, anxiety, and PTSD symptoms—
common comorbidities in veterans with TBI. The “gold standard” for insomnia treatment is Cognitive Behavioral
Treatment for Insomnia (CBTi). However, ~40% of individuals with insomnia do not respond to CBTi. In this
study, we will capitalize on an on-going DoD-funded cohort of 160 active-duty personnel with insomnia to test
the overarching hypothesis that among patients with insomnia, those with TBI vs. no-TBI will manifest higher
levels of systemic inflammation and inferior responses to CBTi. Participants will be divided into 4 groups: Group
A (no insomnia, no TBI), Group B (Insomnia only, no TBI), Group C-low (Insomnia + low grade TBI), and Group
C-high (Insomnia + high grade TBI). Participants will age, sex match across all groups and further match with
age-related chronic conditions, and medication history. All participants completed a baseline blood collection
and clinical assessment. Participants diagnosed with insomnia completed a 60-minute CBTi sessions over 6
weeks and returned 12 weeks after baseline enrollment for blood collection and clinical evaluation. Peripheral
blood samples will be sequenced (RNA-seq) at baseline and after CBTi for evaluation of gene expression
profiling and bioinformatics analysis. We will test the following hypothesis:
Aim 1 will test the hypothesis that insomnia severity and the corresponding baseline (pre-CBTi) peripheral blood
inflammatory status displays a hierarchy: Groups C-high > C-low > B > A.
Aim 2 will test the hypothesis that the CBTi-associated reductions in insomnia severity will display a hierarchy
(best to worst): group B > C-low > C-high; correspondingly, the associated reduction in inflammatory status will
be most, intermediate, and least in these groups, respectively.
Using well-established bioinformatic approaches in the nominee’s mentor’s laboratory, genes that are
differentially expressed between study groups will be identified, and mechanistic pathways associated with the
proposed hierarchy will be determined. We will utilize a recently developed a strategy to categorize gene
signatures into those that relate to immunocompetence vs. inflammation. With this framework, we anticipate that
expression levels signifying the conjoined high immunocompetence-low inflammation state will be
overrepresented in controls/no-insomnia group vs. those with insomnia. We anticipate that the hallmark of the
insomnia/high grade TBI group to be characterized by low immunocompetence-high inflammation. Improving
sleep is the first step in optimizing rehabilitation strategies and the proposed study will provide novel insights to
help improve sleep in Veterans with and without risk of previous TBIs. These insights may have long-term
implications to the health and well-being of veterans, including identification of potential biomarkers (gene
expression) to assist in prognostication and monitoring treatment. The proposed study will also have a relatively
equal representation of men and women, which can further help inform gender-specific care in the military and
Veteran health care system and for the development of military and Veteran health policy. The long-term
beneficiaries from this study will be individuals with insomnia in the chronic phase of recovery from TBI. The
research proposed coupled with expertise of the mentors, provides the nominee with an unparalleled opportunity
to expand critical skillsets necessary to develop a pragmatic, translational ‘omics’-based sleep medicine program
within the VA system that is broadly applicable to many diseases beyond insomnia.

Public health relevance
Insomnia is a common sleep disturbance in service members and veterans and is especially prevalent in individuals with a history of traumatic brain injury. Long-term untreated insomnia can lead to a wide range of negative health concerns such as mood and anxiety disorders, respiratory and neurologic conditions, chronic pain, cardiovascular disease, and diabetes. Although cognitive behavioral therapy is the gold standard treatment for insomnia, not all individuals respond to the treatment. This research will examine the mechanisms associated with cognitive behavioral therapy effectiveness in military service members with insomnia and history of traumatic brain injuries. Improving sleep is the first critical step in optimizing and enhancing rehabilitation approaches in veterans, and our results could provide tractable solutions to strengthen existing rehabilitation or identify novel therapeutic approaches.